Predictive Drug Release from a Tunable Injectable Capsule

PROJECT SUMMARY
Millions of people are affected by chronic conditions, and the number will continue to rise due to increased life
expectancy. These diseases, including wet age-related macular degeneration (AMD), rely on frequent local
injections for disease management. Frequent injections required for maximum therapeutic efficacy are
associated with barriers to care including patient discomfort, high treatment costs, and risk of complications.
There is a clinical need to reduce injection frequency while maintaining treatment efficacy for these chronic
diseases to improve treatment outcomes and quality of life for these patients. The overall objective of this project
is to develop a tunable, injectable, biodegradable microcapsule delivery device that has the potential to sustain
release of therapeutics of varying molecular weights for at least 12 months. Theoretical modeling will be
combined with in vitro and in vivo experimental studies to optimize the microcapsule system and predict
therapeutic release. In Aim 1, microcapsule porosity will be modulated using two methods to tune therapeutic
release. Release of therapeutics of varying molecular weights, including anti-VEGF (vascular endothelial growth
factor) and triamcinolone acetonide (TA), will be evaluated at least 12 months. Therapeutic release rates and
bioactivity will be assessed in vitro by evaluating samples using ELISA, Ultra Performance Liquid
Chromatography (UPLC), endothelial cell tube formation assays, and inhibition of inflammatory markers in retinal
cells. An in silico model for drug release dependent on porosity and drug size will be refined. In Aim 2,
microcapsule outer polymer layer thickness will be modulated to tune therapeutic release. Long-term release
rates and bioactivity of anti-VEGF and TA will be evaluated in vitro. The in silico model will be refined and
validated for drug release dependent on capsule layer thickness. In Aim 3, microcapsule biocompatibility and
pharmacokinetic distribution of the therapeutics will be evaluated in vivo. The microcapsule will first be evaluated
for 1 month for short-term biocompatibility. Then, fluorescently labeled therapeutics will be loaded into optimized
microcapsules and compared to blank capsules and therapeutic only controls for 12 months. Fluorophotometry
will be used to quantitatively assess therapeutic concentrations released over time and will be compared to
assays conducted on extracted ocular tissues at study termination. Results will be compared to published studies
for effective therapeutic concentrations. This study will also provide 12 month in vivo safety data. The in silico
model will be refined to include measurements of therapeutic concentrations in the vitreous and retina to predict
in vivo distribution coupled to drug release from a capsule. Additionally, a computational tool will be developed
for optimizing capsule layer thickness and porosity for specified release duration, pharmacokinetic tissue
distribution, and therapeutic size. The goal of this project is to develop a tunable drug delivery device with the
potential to reduce injections to one time per year, improving the quality of life for patients with AMD or other
chronic diseases that rely on local injections for treatment.

Public health relevance
PROJECT NARRATIVE Many chronic conditions, including age-related macular degeneration, rely on frequent local injections for disease management, which are associated with barriers to care including patient discomfort, high cost, and adverse events. The overall objective of this project is to develop and validate an injectable, biodegradable microcapsule that can be tuned to extend release of therapeutics of varying sizes, including anti-VEGF and triamcinolone acetonide, at least 12 months, thereby reducing the need for frequent injections. Theoretical modeling will be combined with in vitro and in vivo experimental studies to optimize the microcapsule system and predict therapeutic release.